Evolutionary Tradeoffs in Antibiotic Resistance

ABSTRACT
Antibiotic resistance emerges when a mutation in a bacterium causes a previously inhibitory concentration of a
compound to become survivable. Through the accumulation of mutations conferring varying increases in
resistance, already many easy-to-treat infections have become nearly incurable, and are spreading in part
anthropogenically. The classical model of resistance evolution, that a resistant mutant has a fitness advantage
in the presence of antibiotic use, and so spreads in the population to near fixation, captures the rise of
antibiotic resistance, but on closer inspection fails to explain several critical features of resistance. Antibiotic
resistance rarely reaches fixation in clinical populations and more importantly, sensitivity is higher than the
population-genetic models would predict. Further, despite the widespread prevalence of antibiotic-producing
bacteria in the environment, these same bacteria remain surrounded by sensitive neighbors. For these reasons,
we hypothesize that the existing model of resistance evolution is incomplete, and that there exist evolutionary
factors in the environment which have a potentially countervailing effect on resistance evolution. Our
laboratory studies tradeoffs in bacterial evolution with a particular eye towards antibiotic resistance.
Resistance provides an almost ideal model system for the study of microbial evolution; fitness can be well
defined, imposed selective pressures can be readily tuned, and can emerge either spontaneously or by
horizontal gene transfer. Similarly, we study the direct and indirect evolutionary costs of resistance evolution
and specialization, and the tradeoffs inherent in mobile genetic elements-borne resistance. In the next five
years we will be pursuing a number of related projects deepening and expanding this theme: We will explore a
number of a directions related to plasmids and horizontal gene transfer, including their competition with one
another on the individual bacterium and population scales, as well as multiple aspects of the interactions
between mobile genetic elements and resistance genes and bacteriophage. We will also expand into discovering
new mobile genetic elements and their cargo in the wild. We will also relate this historically to the evolution of
antibiotic resistance observed over the last eighty years of clinical use. We will continue to pursue this with a
mix of laboratory evolution in model systems, and computational analysis and modeling of sequence data.

Public health relevance
PHS NARRATIVE Antibiotic resistance in bacteria is a public health crisis. Understanding the evolutionary dynamics that result in the emergence or suppression of resistance will open new avenues of approach to antibiotic resistance. For individual patients with long-term infections it would allow the development of new therapies which consider and potentially exploit the evolutionary possibilities of the pathogen, while on the population scale, understanding which broad dynamics are important for resistance to spread or be contained could enable new public health strategies.